Real-time Predictors of Prescription Drug Misuse by College Students and Assessment of Misuse on Their Developmental Trajectories

PROJECT SUMMARY/ABSTRACT No change

Public health relevance
PROJECT NARRATIVE No change